Project 4: Targeting ATR in TP53-mutated MDS/AML

PROJECT SUMMARY/ABSTRACT
Mutations of TP53 are present in approximately 10-15% of cases of de novo acute myeloid leukemia (AML) or
myelodysplastic syndrome (MDS) and approximately 35% of cases of therapy-related MDS/AML. The presence
of TP53 mutations is an adverse prognostic factor that outweighs other known variables. Indeed, only ~30% of
patients with TP53-mutant AML respond to standard induction therapy with a median survival of 5-9 months. We
and others showed that hypomethylating agents have therapeutic activity in TP53-mutated MDS/AML. However,
mutation clearance is rarely complete and nearly all patients relapse. Thus, there is a pressing unmet clinical
need for more effective therapies for TP53-mutated MDS/AML. Our preliminary data show that TP53-/- AML cells,
while resistant to cytarabine and daunorubicin, are sensitive to decitabine. Using DNA fiber assays and
immunoblotting, we show that decitabine induces DNA replication stress and ATR activation, which is
accentuated in the absence of p53. Thus, p53 is required for the efficient resolution of DNA replication stress
induced by decitabine. Based on these data, we hypothesize that TP53-mutated MDS/AML is selectively
sensitive to ATR inhibition when combined with decitabine-induced DNA replication stress. Consistent
with this hypothesis, we show that combined treatment with an ATR inhibitor (ATRi) and decitabine induces
strong synergistic killing of TP53-/- AML cell lines. To develop the therapeutic potential of ATRi plus decitabine
for TP53-mutated MDS/AML, the following aims are proposed.
Aim 1. Characterize the therapeutic activity of ATR inhibition in combination with decitabine in TP53-
mutant MDS/AML. We will conduct an open-label, phase I study of the oral ATR inhibitor, camonsertib, in
combination with oral ASTX727 (decitabine/cedazuridine) in patients with AML or high-risk MDS through the NCI
Experimental Therapeutics Clinical Trial Network (ETCTN).
Aim 2. Define the molecular mechanisms by which decitabine synergizes with ATR inhibition in TP53-
mutant AML. Based on preliminary data, we have identified the following key questions that will be addressed
in this aim, including: 1) does ATRi + decitabine induce mitotic crisis; 2) is the synergy of decitabine with ATRi
dependent on DNA hypomethylation: 3) what role does p53-induced CDKN1a (p21, CIP) play in decitabine-
induced cytotoxicity; and 4) what are the ATR-dependent (and independent) genes that contribute to decitabine-
induced killing in TP53-mutated AML
We believe that the results of this study will provide evidence of safety, pharmacodynamic evidence of target
engagement, and preliminary evidence of efficacy to support further testing in randomized phase 2/3 studies.
The molecular studies in Aim 2 should provide new insight into how the loss of p53 sensitizes AML cells to DNA
replicative stress and may identify new targets for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE The prognosis for patients with acute myeloid leukemia (AML) or myelodysplastic syndrome (MDS) carrying TP53 mutations is dismal and there is an urgent need for better therapies. We have generated preclinical data suggesting that TP53-mutated AML/MDS is selectively vulnerable to the combination of decitabine and an ATR inhibitor. Here, we will conduct and phase I clinical trial of this novel combination therapy in patients withTP53- mutated AML/MDS.